A vaccine targeting mosquito metabolic pathways to eradicate malaria

ABSTRACT
The World Health Organization, NIH/NIAID, and other public health organizations have recently highlighted the urgent
need for a mosquito pathogen transmission-blocking vaccine (TBV) to be used alongside the recent RTS,S, and R21 vaccines
to eradicate malaria. Unlike traditional vaccines, TBV immunization is not of direct individual benefit. When an Anopheles
mosquito feeds on a TBV-immunized human, it ingests antibodies that interrupt the development of Plasmodium
gametocytes into infectious sporozoites, preventing the mosquito from transmitting the pathogen to the next person. As
a result, this process disrupts the cycle of Plasmodium in mosquitoes and helps reduce its spread to humans within the
community. We have developed a prototype TBV candidate that targets four novel metabolic proteins in mosquitoes.
Preliminary data demonstrate a complete blockage of Plasmodium berghei transmission from mice to mosquitoes. Our
long-term goal is to create a vaccine that disrupts the transmission cycle of malaria in community settings in the developing
world. Our customers are global health and government organizations that call on TBVs to eradicate malaria. Surveys
report that the populations currently using anti-malarial vaccines and deploying various chemical and physical
interventions are very open to integrating a new TBV. This proposal aims to refine our TBV candidate by (i) removing
antigens that do not contribute to transmission-blocking and (ii) extending our findings to the human pathogen
Plasmodium falciparum.

Public health relevance
NARRATIVE Nearly half of the world's population is at risk of malaria, with high rates of morbidity and mortality and significant social and economic costs. The introduction of the RTS,S, and R21 vaccines marks a significant achievement; nevertheless, in light of the limitations of these vaccines, the World Health Organization, NIH/NIAID, and other health organizations recently emphasized the urgent need for complementary strategies such as a mosquito pathogen transmission-blocking vaccine (TBV) to achieve eradication of malaria. This project will develop a novel TBV candidate, a relatively new class of vaccines that aims to interrupt the malaria parasite within the mosquito.